INSULIN THERAPY, GLUCOSE CONTROL IN IDDM, INSULFLON CATHETER

To study the influence of intensified insulin therapy on HbA1 levels in children and adolescents with persistent high blood glucose values (HbA1 values > 10%. To study the effect of the Insuflon catheter and to monitor indwelling duration of Insuflon and incidence of side effects and their impact on compliance.